Biosynthesis of Marine Polyketide Antibiotics

Project Summary / Abstract

The emergence of antibiotic resistance has created a global dilemma for the need to discover
new antibacterial lead agents. Realizing this critical need for new antibacterial agents with new
structure types and targets, we focus here on the biosynthetic interrogation and development of
structurally distinct marine bacterial natural products. An underlying theme associated with
many marine microbial antibiotics involves the use of aromatic polyketide frameworks that have
undergone extensive oxidative tailoring reactions catalyzed by halogenase and oxygenase
biosynthetic enzymes. In this application, we propose a multidisciplinary project involving
heterologous biosynthesis, mechanistic enzymology, atomic resolution protein X-­ray
crystallography, chemoenzymatic synthesis, and genetic engineering to understand and control
the molecular basis of polyketide diversification in a series of marine bacterial compounds with
promising antimicrobial properties. To accomplish the broad goals outlined in this application,
we propose four specific aims. First, we plan to functionally and structurally characterize diverse
meroterpenoid V-­dependent chloroperoxidases and their catalytic properties in promoting
antimicrobial chemical diversity. Second, we will discover, characterize, and engineer
biosynthetic pathways for structural diversification of halogenated pyrrole containing bioactive
natural products. Third, we aim to functionally characterize the unprecedented biosynthesis of
thiotetronic acid polyketide antibiotics and apply new biosynthetic reactions to extend the
synthesis and bioengineering of novel molecules. And fourth, we will interrogate the
antimicrobial activity and mechanism of new meroterpenoid, bipyrrole, and thiotetronate
compounds.

Public health relevance
Public Health Relevance Statement The majority of clinically used antibiotics are derived from nature, and of those, most are produced by related soil bacteria. Realizing the critical need for new antibiotics to combat increasing bacterial resistance to known antibiotic drugs, antibacterial agents from marine microbes are emerging as promising drug leads due to their distinctive chemical structures. This application investigates novel biosynthetic enzymes that construct and diversify polyketide antibiotics from underexplored marine bacteria. Anticipated outcomes of this research project will be the discovery of new biosynthetic reactions in natural product diversification and the application of this basic knowledge to the (chemoenzymatic) synthesis and bioengineering of designer agents for biological evaluation in antibacterial screens.